Structural biology collaborations

We are using the expertise and the state of the art cryoEM technology in the Center of Structural Biology to assist our intramural collaborators on a number of projects. Specific projects include: 1) trying better to understand how the complexes formed under the cellular membrane drive T-cell development; 2) how protein-RNA complexes regulate translation and transcription and 3) how folded RNAs regulate activity by shifting conformational space. We anticipate additional projects over the coming year.